Mining Cryptic Biosynthetic Gene Clusters for Novel Bioactive Compounds

PROJECT SUMMARY/ABSTRACT
Natural products from the soil-dwelling bacteria Streptomyces have been a rich source of medicines, including
antimicrobials and anticancer agents. Unfortunately, discovery of novel bioactive natural products from
Streptomyces using traditional techniques is often unsuccessful due to the re-discovery of known molecules.
Genome sequencing suggests that Streptomyces are capable of making many more (likely hundreds-of
thousands more) molecules than those typically observed in the laboratory. However, the biosynthetic
machinery responsible for producing these novel natural products is often cryptic (i.e. transcriptionally inactive).
Co-culture of Streptomyces with other microorganisms induces production of natural products not observed in
monocultures. However, the signals that control this induction are poorly understood. A significant gap remains
in the strategies available to discover new bioactive natural products from cryptic biosynthetic gene clusters. Our
long-term goal is to develop strategies to overcome this gap, thus maximizing the natural product potential from
Streptomyces. Over the next five years, we aim to identify small molecules capable of inducing natural product
production (i.e. chemical elicitors, Project 1) as well as utilizing state-of-the-art bioinformatics to predict and
directly chemically synthesize natural products (Project 2). Low levels of certain antibiotics have been found to
induce production of a few natural products. The generality of this effect remains unknown, as does the
mechanism by which these compounds induce production of natural products. The objectives for the first project
are to 1) Study the ability of mechanistically distinct antibiotics to act as chemical elicitors in a variety of distantly
related Streptomyces strains and 2) Determine the mechanisms of the chemical elicitors. This work will provide
a greater understanding of antibiotic regulation of natural product production, which will allow both our laboratory
and others to activate production of natural products in a more targeted manner and ultimately increase the
number of bioactive natural products that we as a community can discover. In the second project, we are directly
chemically synthesizing cyclic peptide natural products that are bioinformatically predicted from non-ribosomal
peptide synthetase biosynthetic gene clusters. Cyclic peptides are an important family of natural products,
including many FDA-approved drugs. Their large size and rigidity allows them to target challenging-to-hit targets
(e.g. protein-protein interactions). The objectives for the second project are to 1) Develop a bioinformatics
method to identify cryptic non-ribosomal peptide synthetase genes that encode production of diverse cyclic
peptides, 2) Chemically synthesize a library of several hundred of the predicted cyclic peptides, 3) Use the library
to study the rules that regulate peptide cell-membrane permeability and 4) Screen the library for antibiotic and
anticancer activity. This work will provide access to hundreds of previously inaccessible natural products that will
be useful tools for the study of cyclic peptide membrane permeability and will likely have interesting bioactivities.

Public health relevance
PROJECT NARRATIVE The soil-dwelling bacteria Streptomyces make numerous molecules that humans use as medicines. Analysis of the DNA of these bacteria suggests they have the potential to make many more useful molecules, but they do not make them under standard laboratory conditions. The objectives of this proposal are to 1) discover chemical elicitors that induce the production of these molecules, to understand their mechanisms of induction, and to use these elicitors to identify novel bioactive natural products and 2) to use organic synthesis to access bioinformatically predicted natural products that are currently inaccessible using other means.